Exploiting emerging ideas in G protein-coupled receptor biology and pharmacology to treat asthma

Overall Program Abstract For this NHLBI PPG we have assembled a highly collaborative team of experts in G
protein-coupled receptor (GPCR) biology, airway smooth muscle (ASM) biology, and asthma biology to pursue
the theme of “exploiting emerging ideas in G protein-coupled receptor biology and pharmacology to treat
asthma.” The Program expects to achieve the following goals: 1) Identify novel targets and targeting molecules
involving GPCR regulation of ASM contraction and proliferation; 2) Delineate the mechanisms by which these
novel targets/targeting molecules regulate these ASM functions; and 3) Establish the therapeutic utility of novel
targeting molecules in in vivo models of asthma. These goals will be accomplished across 4 scientific projects,
two scientific cores, and an administrative core, to test the central hypothesis that novel modes of GPCR
regulation can be targeted to effect superior management of ASM function and asthma. Each project takes
advantage of a robust experimental strategy that incorporates multiple cell, tissue, and in vivo models of ASM
function, complemented by cutting-edge biochemical analyses to detail mechanisms of action. Project 1 will test
the ability of, and mechanisms effected by, recently-developed biased β2AR ligands to manage ASM contractility
and the asthma phenotype, while (with Core A) leveraging recent insight in β2AR structure-activity relationship
to develop new ligands superior to in-hand leads. Project 2 pivots away from the receptor locus as a means to
regulate GPCR control of ASM, to explore the role of the cAMP transport inhibitor ABBC1, positing that ABBC1-
dependent pathways inhibit β-agonist effects on HASM E-C coupling, and are upregulated in asthma patients.
Project 3 similarly explores regulation of downstream Gq-coupled receptor signaling by diacylglycerol kinase
(DGK), whose targeting effectively inhibits pro-contractile and pro-mitogenic GPCR signaling in ASM to control
the asthma phenotype. Project 4 breaks new ground in the exploration of Class C GPCRs, clarifying the roles of
GPRC5A and GPRC5B in ASM and asthma biology, and in collaboration with Core A, developing new ligands
to skew the signaling competition between these 2 receptors towards therapeutically beneficial GPRC5A
signaling and away from pathogenic GPRC5B signaling. The four projects will be supported by Core A, which
will employ high-throughput screening of diverse libraries of arrayed and expressed small molecules, and further
employ structural biology, computational modeling and virtual screening to leverage screening results, predict
and test novel drug-like molecules. Core B will provide all de-identified human cell and tissue models to study
novel mechanisms regulating EC coupling in HASM. Core C will provide administrative support for the program.
Each project also collaborates with other projects to test combination strategies that target receptors (β2AR,
GPR5A, GPR5B) in conjunction with downstream regulators (ABCC1, DGK). The strengths of this Program are
the common focus on a single theme and the productive working relationship among investigators with the ability
to apply cutting-edge GPCR biology to key questions in asthma biology and pharmacology.

Public health relevance
Overview Project Narrative Asthma is a complex syndrome with significant health and economic impacts, affecting over 25 million people in the US. This multi-project proposal seeks to establish new ways to target mechanisms that cause asthma, by focusing on the development of new drugs and new strategies that can be rapidly translated to the clinic.